Development of a novel visualization, labeling, communication and tracking engine for human anatomy.

The key to tracking, collating, and communicating skin cancer data is standardization, enhanced
precision, and categorization of anatomic descriptions. Imprecise and non-standardized
labeling of anatomic sites for skin cancer biopsies creates challenges in communicating and
identifying the skin cancer location at the time of treatment. Diagnostic biopsies often remove
the visible cancer cells, and since skin cancer most commonly arises on sun- or
radiation-damaged skin with numerous surrounding or contiguous discolorations, lesions, and
scars, the biopsy site can be difficult to find. Furthermore, photos are not always taken at time
of biopsy or are not readily available at time of surgery, and most Electronic Health Record
(EHR) systems rely on free-text labeling of anatomic sites. This project aims to create methods
to document reproducible and standardized anatomic site descriptions of skin cancer locations,
to visualize skin cancer locations, and to attach data related to skin cancers at each affected
anatomic site. The anatomic site descriptions are also enhanced with standardized directional
modifiers for increased accuracy and precision, thereby creating a linguistic global position
system (GPS) for the human body. The project involves a simplified process to attach skin
cancer diagnoses and diagnostic codes to standardized anatomic sites with enhanced
descriptions and visualizations across the skin surface topography. Precise and standardized
anatomic labeling with corresponding visualizations will facilitate communication between
clinics, increase clinical accuracy and efficiency, and enhance patient safety and understanding
by reducing the risk of wrong-site surgery for skin cancer. The project also integrates
functionality to securely send files including high resolution, color skin cancer photos and
corresponding anatomic map visualizations linked to standardized anatomy descriptions through
email, thus mitigating the need to communicate photos and records over poor-quality fax
methods or postal mail, while simultaneously maintaining compliance with regulatory statutes.

Public health relevance
Imprecise and non-standardized labeling of anatomic sites for skin cancer biopsies creates challenges in communicating and identifying the skin cancer location at the time of treatment. This project aims to create a simplified process to document and securely communicate reproducible and standardized anatomic site descriptions of skin cancer locations, visualizations of skin cancer locations, and attachment of data related to skin cancers at each affected anatomic site. The anatomic site descriptions are also enhanced with standardized directional modifiers for increased accuracy and precision and the descriptions can be securely communicated to clinics on different systems through email.